Microbiome Contributions to Age-Associated Cognitive Decline

PROJECT SUMMARY/ABSTRACT
Aging is an inexorable, multifactorial process in which organisms lose fitness and ability to maintain
homeostasis. With advances in modern medicine and standards of living across the globe, life expectancy, and
thus aging, is set to expand rapidly. Cognitive decline due to Alzheimer’s disease and other age-associated
dementias is one of the most debilitating aspects of aging, robbing millions of people of everyday function and
independence. Healthier aging and independence are potentially worth trillions of dollars in addition to
unquantifiable social and emotional benefits. As we get older, our cells are not the only thing in our body that
age. The microbiome is the collection of trillions of microorganisms that inhabit our gastrointestinal tract. Like
organ systems, the microbiome also changes with age, losing diversity and gaining deleterious species. It is
widely accepted that the microbiome plays an important role in metabolism, digestion, and obesity, but recently
it has also been linked to disease processes in the brain, such as autism and depression. The vagus nerve
connects the central and enteric nervous systems to mediate gut-to-brain signaling, and its ablation has been
shown to induce cognitive deficits in rats. Additionally, it has also been shown that performing fecal microbiome
transplants (FMT) from old mice into young germ-free mice induces cognitive deficits. In initial experiments, I
have shown that passive transfer of the microbiome by cohousing young and old mice induces cognitive
deficits in young mice. This effect is not seen in cohoused germ-free or antibiotics-treated mice and is
reproduced upon FMT into young germ-free mice from old stool donors. Ablating or inhibiting afferent vagal
neurons also induces a cognitive deficit, while vagal stimulation with low dose capsaicin or hormonal activation
reverses deficits associated with the aged microbiome. Thus, I propose that the aged microbiome impairs
cognition through inhibition of gut-to-brain signaling. To explore this, I will first use bacterial sequencing to
identify bacterial species in the aged microbiome that are sufficient to induce cognitive deficits (Aim 1). Next, I
will determine which components of gut-to-brain signaling are required for learning and memory (Aim 2).
Finally, I will characterize the effects of the aged microbiome with brain-wide mapping of neuronal activation
during memory encoding (Aim 3). These studies will provide insight into understudied mechanisms of aging
and potentially identify new targets to combat age-associated cognitive decline. I have collected a significant
amount of preliminary data and possess the tools and skills required to pursue these aims. The institutional
support and resources of the University of Pennsylvania, along with the expertise and mentorship of my
sponsors, Dr. Virginia Lee, internationally renowned for her research in neurodegeneration, and Dr. Christoph
Thaiss, a microbiome expert, maximize my chances at success. The training I will receive during this proposal
will position me to be a future leader in aging and neurodegeneration as a physician-scientist.

Public health relevance
PROJECT NARRATIVE Age-associated cognitive decline is a significant public health challenge with no effective treatments that will only have increased disease burden with an aging population. Studies of age-associated changes in the gut microbiome and its effects on disease, especially cognitive decline, are limited. Determining the role of the microbiome in age-associated cognitive decline has the potential to identify novel mechanisms and therapeutic targets to combat aging.